Research Project III - Vesicant-Induced Lung Injury

Research Project 3. Vesicant-induced Lung Injury
Project Lead: Debra L. Laskin, Ph.D.
Co-Investigator: Jeffrey D. Laskin, Ph.D.
Co-Investigator: Vasanthi Sunil, Ph.D.
Co-Investigator: Rama Malaviya, Ph.D.
Co-Investigator: Raymond Rancourt, Ph.D.
Project Summary/Abstract
Lung injury following exposure to mustard vesicants is responsible for most morbidity and mortality of these
high priority chemical threat agents. As there are currently no approved therapeutics to treat mustard
poisoning, it is essential to identify mechanistic targets for drug development. Our focus is on inflammatory
macrophages and mediators they release which we have demonstrated contribute to both acute lung injury
and chronic disease induced by sulfur mustard and nitrogen mustard. One macrophage derived
proinflammatory mediator that we discovered is key in mustard lung toxicity is tumor necrosis factor alpha
(TNFα). Based on our findings, Janssen Pharmaceuticals is now working to move SimponiR, a fully humanized
anti-TNFα antibody, into advanced development for treatment of mustard lung poisoning with funds from
BARDA. In recent studies we discovered that farnesoid-X receptor (FXR), a nuclear receptor important in bile
acid metabolism with anti-inflammatory activity is also important in mustard lung toxicity. Following nitrogen
mustard exposure, macrophage FXR activity is suppressed. This is associated with increased activity of
proinflammatory macrophages and reduced activity of anti-inflammatory/proresolution macrophages. Studies
during the next grant period are aimed at elucidating mechanisms underlying nitrogen mustard induced
suppression of FXR. In preliminary studies we found that microRNAs that regulate the proinflammatory
transcription factor NFκB in macrophages are dysregulated after nitrogen mustard exposure. As a
consequence, there is protracted activation of NFκB signaling resulting in increased production of TNFα and
cytotoxic reactive nitrogen species. We hypothesize that these mediators suppress FXR and its target, NR4A1,
a central regulator of macrophage reprogramming from a proinflammatory to an anti-inflammatory phenotype.
To test this hypothesis, we will (1) Analyze the impact of reduced FXR activity on the development of anti-
inflammatory/proresolution macrophages and lung injury following mustard exposure; and (2) Determine if
protracted activation of NFκB is due to mustard-induced alterations in microRNAs regulating NFκB and key
downstream inflammatory gene products, TNFα and inducible nitric oxide synthase. Results of these studies
will lead to new mechanistic insights into mustard lung poisoning and the development of novel therapeutics for
mitigating toxicity.